AnnexinA2/progastrin and stem cells: dietary cancer prevention

DESCRIPTION (provided by applicant): Cumulative evidence strongly suggests that precursor peptides such as progastrins (PG) exert mitogenic/co-carcinogenic effects on target cells and increase the risk of tumorigenesis. Many tumors express PG, and down-regulation of gastrin gene/PG expression attenuates growth of PG-dependent cancer cells. We recently discovered that extra-cellular membrane-associated annexin A2 (ANXA2) represents a novel receptor for PG. At the same time, ANXA2 expression has been reported to be critical for maintaining the growth of epithelial cancer cells. More recently, we discovered that over-expression of PG in HEK-293 cells significantly increased stem cell populations, positive for DCAMKL+1/Lgr5/CD44, and surprisingly resulted in tumorigenic transformation of the cells. In an important related study we reported potent inhibition of PG stimulated growth on cancer cells via the inhibition of critical signaling pathways. Our preliminary studies suggest that curcumin significantly reduces expression of ANXA2 and stem cell markers; intriguingly opposite effects of curcumin were measured on DCAMKL+1 expression in transformed versus non-transformed epithelial cells, Based on these novel findings we will test the hypothesis that 'chemo/dietary preventive agents differentially modulate growth factor-mediated expression of ANXA2 and stem cell markers in non-tumorigenic versus tumorigenic epithelial cells'. Towards this goal, we will focus on examining the effects of curcumin. In Aim 1, relative inhibitory efficacy of curcumin on growth of non-transformed/transformed epithelial cells, enriched for ANXA2/stem cell markers will be examined using in vitro and in vivo models of investigation. Regulatory effects of curcumin on expression of ANXA2/stem cell markers in non-tumorigenic/tumorigenic cells will be examined in relation to growth inhibitory effects of curcumin. Target-specific siRNA/shRNA against stem cell markers will be used to augment inhibitory effects of curcumin. Results of these studies will likely have therapeutic implications. In Aim 2 mechanisms by which curcumin reduces stimulatory effects of PG on the expression of ANXA2/stem cell markers will be examined in transformed/non-transformed cell lines at protein and RNA levels; inhibitory effects at the transcriptional level will be examined in promoter-reporter assays. These experiments will expand our understanding of the interplay between growth factors, curcumin and stem cell markers. In Aim 3, dose-dependent effects of dietary curcumin against initiation, promotion, and progression phases of colon carcinogenesis in transgenic mice over-expressing PG, in relation to efects on ANXA2/stem cell markers will be examined. Pre-neoplastic and neoplastic growths and surrounding normal mucosa wil be analyzed for relative expression of ANXA2/stem cell markers in relation to activation of 2- catenin/NF:Bp65 and other transcriptional factors. Results of these studies are expected to help us develop mechanism-based strategies for prevention and/or treatment of cancers in patients, positive for circulating PG (growth factors) and/or ANXA2 expressing tumors.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this grant application it is proposed to examine if a combination of dietary supplements and non- toxic small inhibitory molecules can prevent or treat the growth of solid tumors and eradicate the seed cancer cells so that the threat of recurrence is significantly reduced. We will also examine the mechanisms by which specific molecules, discovered in the past few years by our laboratory, increase the risk of developing cancerous growths, and the mechanisms by which dietary agents reduce this risk. The results of these studies are expected to help us develop more effective strategies for preventing and treating solid tumors in organs such as the colon, using less toxic methods. Project Narrative In this grant application it is proposed to examine if a combination of dietary supplements and non- toxic small inhibitory molecules can prevent or treat the growth of solid tumors and eradicate the seed cancer cells so that the threat of recurrence is significantly reduced. We will also examine the mechanisms by which specific molecules, discovered in the past few years by our laboratory, increase the risk of developing cancerous growths, and the mechanisms by which dietary agents reduce this risk. The results of these studies are expected to help us develop more effective strategies for preventing and treating solid tumors in organs such as the colon, using less toxic methods. __SpecificAimsTextDelimiter__ Specific Aims. In the past funding periods, we have investigated the mechanisms by which growth factors (including progastrin [PG]) increase the risk of colon carcinogenesis. During these investigations, we made a very important discovery that the extracellular membrane associated protein annexinA2 (ANXA2), is a novel receptor for PG (1). Another exciting finding was that when PG is over-expressed in HEK-293 cells (HEK- mGAS cells), there is a marked increase in stem cells, based on positive staining for DCAMKL+1/Lgr5/CD44, and tumorigenic transformation of HEK-mGAS cells (2, progress report); control HEK-293 cells (HEK-C) lacked significant tumorigenic potency. Activation of NFκB/β-catenin signaling pathways in response to PG (3- 5), may have contributed to up-regulation of stem cell populations and malignant transformation of HEK- mGAS cells. Importantly, ANXA2 expression was required for measuring up-regulatory effects of PG on NFκB/β-catenin and stem cell markers (6, progress report). A related important finding is that curcumin potently inhibits the proliferative/anti-apoptotic effects of PG (7). In preliminary studies we show that curcumin significantly reduces the expression of ANXA2 and stem cell markers. Intriguingly, curcumin had opposite effects on DCAMKL+1 expression in transformed versus non-transformed cells. Based on these observations, our overall hypothesis is that 'chemo/dietary preventive agents differentially modulate growth factor-mediated expression of ANXA2 and stem cell markers in non-tumorigenic versus tumorigenic epithelial cells'. Towards this goal, we will focus on examining the effects of curcumin/PG in in vitro and in vivo models. We further speculate that concepts developed as a result of these studies will apply to other dietary agents, growth factors and cancer cells. The above hypothesis will be examined in the following three aims. Aim 1. To examine inhibitory eficacy of curcumin on growth of non-transformed/ transformed epithelial cells, enriched for ANXA2/stem cell markers. For in vitro studies in a), we will use non-tumorigenic/tumorigenic epithelial cell lines (HEK-293/colon cancer), enriched for ANXA2/ stem cell markers, in the presence or absence of autocrine PG expression. Effect of curcumin on expression of ANXA2/stem cell markers will be examined in relation to growth inhibition and spheroid formation (which selects for stem cells). We will learn if inhibitory effects of curcumin correlate with expression of ANXA2, PG and stem cell markers. To overcome resistance, if any, to curcumin, target-specific siRNA against indicated stem cell markers/ANXA2/PG will be additionally used, to achieve complete regression of cancer and stem cell populations. b) For the in vivo studies, athymic nude mice will be inoculated with luciferase/GFP expressing tumorigenic cells, grown as primary/metastatic tumors. Inhibitory efficacy of injectable curcumin, given as a preventive/therapeutic regimen, will be examined by in vivo imaging of tumors. Resistance to curcumin, if any, will be resolved by injecting nanoparticles containing lentiviral-shRNA expression plasmids, based on results in a). Aim 2. To investigate mechanisms by which curcumin reduces growth-stimulatory effects of PG and the expression of ANXA2/stem cell markers. In preliminary studies, we observed that curcumin inhibits binding/internalization of PG and differentially reduces expression of DCAMKL+1 at the RNA/protein levels, in transformed versus non-transformed cells and. In a), inhibitory effects of Curcumin on PG internalization will be confirmed. In b) promoter-reporter constructs will be used to confirm inhibitory efects of Curcumin on DCAMKL/ANXA2 at the transcriptional level. In c), truncated promoter-reporter constructs and ChIP assays will be used to further define molecular mechanisms by which PG/curcumin differentially regulate expression of DCAMKL+1 in non-transformed (HEK-C) versus PG expressing transformed (HEK-mGAS) cells. These experiments will allow us to reveal the interplay between growth factors, dietary inhibitory agents and stem cell markers. Aim 3. To examine dose-dependent effects of dietary curcumin against initiation, promotion, and progression phases of colon carcinogenesis in transgenic mice over-expressing PG, in relation to effects on ANXA2/stem cell markers. We recently reported potent inhibitory effects of curcumin on autocrine growth/signaling effects of PG on intestinal epithelial cells in culture (7). In order to further validate the physiological relevance of these findings, transgenic mice (Fabp-PG), over-expressing hPG in the intestinal mucosa (8) will be used. The risk of colon carcinogenesis is increased 2-4 fold in response to azoxymethane (AOM) in the Fabp-PG mice when compared to that in wild type (WT) littermates (8). Dietary curcumin will be fed at different points before or after AOM treatment and mice monitored for pre-neoplastic (aberrant crypt foci, ACFs) and neoplastic (Adenomas, Ads; Adenocarcinomas, AdCAs) growths. Colonic lesions and surrounding normal mucosa will be analyzed for relative expression of ANXA2/stem cell markers, activated β-catenin/p65 and the transcriptional factors identified in Aim2 studies. Results of these studies are expected to help us develop mechanism-based strategies for using curcumin and RNAi for prevention (and/or treatment) of epithelial cancers in patients, positive for circulating PG and/or ANXA2 expressing tumors. These findings can be expected to have significant translational value, in terms of diagnostic/therapeutic applications.